Idaho INBRE Program- Equipment Supplement

PROJECT SUMMARY
This Idaho INBRE Program Administrative Supplement will fund equipment that enhances the
microscopic imaging infrastructure in the Imaging and Data Acquisition Core (IDAC) facility at
the University of Idaho (UI). This equipment will increase the technical capacity, accessibility,
and impact of this IDeA-built core in the Institute for Modeling Collaboration and Innovation
(IMCI). The IMCI is a multidisciplinary, collaborative research program housed at the UI and
supported by a COBRE award. Its microscopy capabilities were initiated by INBRE and are part
of the larger INBRE Data Science Core. The IDAC provides confocal microscopy, flow
cytometry, and fluorescence-activated cell sorting to users at UI, INBRE partner institutions, and
other nearby institutions. In FY22, the IDAC supported the research of 19 UI faculty and 42
trainees, from 5 UI Colleges and 9 Departments. Importantly, 12 NIH-funded or NIH grant-
seeking researchers at the UI critically rely on the equipment and technology offered through
the IDAC for their research programs. INBRE, through awards to faculty PIs (i.e. Developmental
Research Project and Pilot Awards) and support of summer INBRE fellows, directly supports
user fees for IDAC equipment. The requested equipment purchase will upgrade and enhance
the previous and ongoing NIH IDeA investments in Idaho infrastructure, equipment, and
faculty/staff related to confocal, widefield, and live microscopic imaging and image analysis. We
propose to purchase a super-resolution structured illumination microscopy (Deep SIM) add-on
to the current Crest X-Light V3 confocal microscope and an additional, independent
epifluorescence/widefield microscope system, to be housed, maintained, and operated in the
IDAC. Neither of these technologies/imaging platforms are currently available in the IDAC, and
super-resolution microscopy is currently not available on the UI campus. Our current
microscopy options are in high demand, including a > 10-year-old spinning disk confocal. With
the additional proposed equipment purchases, IDAC users will be able to access three distinct
microscope technologies (confocal, Deep SIM, widefield). Finally, this purchase will provide the
first user access to super-resolution microscopy on the UI campus. Collectively, this INBRE
administrative supplement will add important equipment to enhance the capabilities for
biomedical researchers statewide.

Public health relevance
PROJECT NARRATIVE This supplement requests critical upgrades at the University of Idaho Imaging and Data Acquisition Core, part of the larger INBRE Data Science Core. The equipment includes a super- resolution structured illumination microscopy (Deep SIM) add-on to the current Crest X-Light V3 confocal microscope and an additional, independent epifluorescence/widefield microscope system. These upgrades will allow Idaho researchers to keep pace with recent surges in demand for high-performance microscopy. This, in turn, will directly contribute to Idaho biomedical research productivity and competitiveness.